Stop, focus, plan, and change: A translational approach to predict parent and child responses to a brief, telehealth parent training

PROJECT SUMMARY / ABSTRACT
The purpose of this K23 Mentored Patient-Oriented Research Career Development Award is to provide the
applicant with advanced training to launch an independent research program focused on improving the
effectiveness of parenting interventions for early childhood populations. Parenting interventions are the first line
of treatment for early childhood mental health concerns due to their benefits on parenting stress and practices
as well as most child emotional and behavioral problems. However, parenting interventions have substantial
engagement issues, and many children show limited to no benefit. The objectives of this K23 are to (a) identify
predictors of suboptimal response to a parenting intervention with well-established efficacy (i.e., behavioral
parent training [BPT]) and (b) to identify ways to modify parenting interventions to benefit those parents, guided
by their input. The central hypothesis is that greater parental executive functioning (EF) difficulties will be linked
to more adverse social determinants of health (SDoHs), and both will diminish parent and child responses to a
brief parenting intervention delivered through telehealth. Parents of children 3 to 7 years with externalizing
concerns will be recruited from two sites – a children’s hospital and a group of Head Start programs – to
receive BPT from trained clinicians. Multiple methods will be used at baseline to measure candidate predictors
(i.e., parental EF, adverse SDoHs) in ecologically valid ways. A mixed methods approach will integrate
qualitative and quantitative results and guide identification of potential adaptations to parenting interventions
needed to achieve their intended benefits. The research project aims to (1) develop and test an ecologically
valid measure of parental EF during parent-child interactions, (2) characterize the roles that parental EF and
SDoH have on treatment response for parent (i.e., parenting stress, harsh parenting) and child outcomes (i.e.,
externalizing concerns), and (3) identify potential adaptations to improve intervention effects among non-
responders. Under the mentorship of a high-quality team including Drs. Laura Anthony, Tina Studts, and Susan
Mikulich, the applicant will acquire advanced training in the following areas: 1) acquire skills in developing and
adapting real-world measures to use in clinical trials, 2) advance knowledge of how SDoHs influence parenting
interventions, 3) gain competencies in mixed methods research, and 4) learn clinical trial methodologies. This
project and training will enable the PI to become an independent scientist focused on discovering ways to
improve the effectiveness of parenting interventions. The proposed training plan and research aims will provide
the PI a foundation to conduct a large-scale trial (R01) testing if tailoring delivery methods (e.g., individual or
group format; in-person or telehealth setting), dose (e.g., lengthen sessions), or content (e.g., target parental
EF) improves the effectiveness of parenting interventions for non-responders. Findings will have significant
implications for interventions that involve parents while treating youth mental health concerns.

Public health relevance
PROJECT NARRATIVE Although parenting interventions can improve the mental health and well-being for both parents and their young children, these intended benefits do not occur for many families. This proposed K23 study will use a prospective, single-arm clinical trial to evaluate potential predictors (i.e., parental executive functioning difficulties and adverse social determinants of health) of suboptimal response and then use mixed methods approaches to identify potential intervention adaptations driven by parent and clinician input. Findings will guide the next R01 proposal testing if adaptations identified within this K23 proposal enhance the effectiveness of parenting interventions at improving parent (e.g., harsh parenting, parenting stress) and child outcomes (e.g., externalizing concerns, irritability).